Project 8: Role of Motor Signals for Perception During Self-Motion

PROJECT SUMMARY/ABSTRACT Role of Motor Signals for Perception during Self-Motion Sensing and reconstructing self-motion is essential for normal everyday function of most mobile organisms. In humans, visual and vestibular systems provide valuable sensory information for self-motion processing, but motor signals also contribute. In particular, oculomotor, neck-motor, and locomotor signals provide information about movement of the eye in the head, the head on the body, and the body through space. These signals serve multiple purposes: they allow transforming sensory estimates between eye, head and body reference frames; they can be used to calibrate sensory signals; and once signals are calibrated, they can be integrated to yield improved sensory-motor estimates of self-motion. Research proposed here will advance our understanding of these sensory-motor interactions during self-motion in the context of the following specific aims. Aim 1 is to characterize principles of sensory-motor comparison and adaptation for head movements. Sensory-motor conflict will be introduced by rotating the body under the head during active head turns to introduce a mismatch between the predicted and observed vestibular sensory signal. Perceptual sensitivity to the conflict and rate of adaptation to the perturbed signal will be measured and compared with predictions of a probabilistic model. Aim 2 is to examine how retinal speed signals are combined with eye and head movement signals to estimate object motion in the world. Prior psychophysics and modeling work has shown that perceived speed is reduced during pursuit and passive head movement, suggesting reduced perceptual gain on eye movement and vestibular signals. This project will extend these approaches to investigate the role of neck-motor signals during active head movement and interactions among neck-motor, oculomotor and vestibular signals. Aim 3 is to measure and model impact of locomotor signals on perceptual thresholds. This project will test the hypothesis that previously observed suppression of vestibular signals during locomotion depends on head movement variability, and thus reliability of locomotor efference copy signals. Head movement variability will be measured and used to predict locomotion-induced changes in perceptual sensitivity to vestibular and other sensory stimuli during different speeds and at different time points during walking on a treadmill. 1

Public health relevance
PROJECT NARRATIVE Role of Motor Signals for Perception during Self-Motion Sensing and reconstructing self-motion is necessary to support a number of behaviors that are critical to normal everyday function, including postural control, locomotion and navigation. The current research will advance our understanding of the role of motor signals in self-motion processing, which has the potential to improve diagnosis, treatment, and rehabilitation methods for a wide array of spatial orientation disorders. 1